OUTPATIENT CLINIC FOR GENETIC AND PHARMACOLOGIC STUDIES OF AFFECTIVE DISORDER

Ascertainment and collection of pedigrees for linkage and association studies. We are in the midst of several pedigree collection efforts, with the emphasis now on affected-sib-pairs. 1. Bipolar illness (Dr. Gershon) -- CNG pedigree series (22 families; currently genotyping 396 individuals), NIMH Genetics Initiative pedigree series (collected at this site: 22 families, entire series now has 97 families with 540 individuals being genotyped). 2. Schizophrenia (Dr. Gejman) -- CNG pedigree series has 57 families being genotyped; 21 other families were collected with identical criteria through collaborations. 3. Panic disorder (Dr. Gershon) 15 families, 101 individuals, currently project is on hold. 4. Same-sex sexual orientation in males (Dr. Gershon): 41 gay sib pairs. 5. Neuroleptic malignant syndrome(Dr. Gejman). Not a pedigree collection; 14 cases collected for mutational analysis of receptor and signal transduction genes. Genetic findings in the Clinical Neurogenetics Branch pedigrees: Linkage to chromosome 18 markers in Bipolar pedigrees is preferentially found in families with clinically observed "transmission" of illness through at least one paternal relative.